Airway trees in the Anthropocene: Defining resilient airway trees and identifying the candidate mechanisms and etiologic factors that increase susceptibility to tobacco smoke and air pollution

11 million lives and 350 million disability-adjusted life-years were lost to tobacco smoke and other noxious pollutants in
2017 (significant increases from 2007). The airway tree is the first line of defense against these ubiquitous noxious agents
and, according to textbooks, has a fairly standard anatomy.
During the first funding period, we confirmed our primary hypothesis and found that approximately 25% of the general
population have airway branch variants that modify susceptibility to cigarette smoke (published in PNAS). Further
epidemiologic investigation of airway tree structure on computed tomography (CT) in multiple cohorts demonstrated that
variation in native airway tree caliber (“dysanapsis”) is common and predicts incident chronic obstructive pulmonary disease
(COPD) better than smoking (published in JAMA) and extends to the terminal bronchioles. These new findings suggest that
native airway tree caliber is fundamental to COPD risk and may modify susceptibility to inhale particulates including
cigarette smoke. This renewal therefore proposes to 1) establish the early-life origins of airway tree caliber to identify
possible modifiable factors, 2) investigate the pathophysiology of increased susceptibility to inhaled noxious agents in
adults, and 3) define resilient vs susceptible airway tree structure using clinical outcomes
We will use new and existing data, and proven expertise in cohort epidemiology, lung imaging, tobacco and air pollution
assessment and gene expression to address the following aims:
Aim 1 Using radiation-free innovative MR lung imaging, we will establish the early-life origin of airway tree caliber
variation that is physiologically relevant among adolescents (n=100) in a well-characterized mulit-ethnic birth cohort.
1a Explore if smaller airway tree caliber is associated with prospectively ascertained and modifiable early-life factors.
Aim 2 Investigate two candidate pathophysiologic mechanisms linking airway tree caliber to increased susceptibility to
tobacco smoke and other noxious pollutants:
2a: Mechanism 1 (higher dose delivered): Determine if smaller airway tree caliber is associated with i) higher baseline
and prospective accumulation of lung macrophage black carbon content (n=554), and ii) higher systemic biomarker levels
of tobacco smoke exposure and inflammation (n=6,570).
2b: Mechanism 2 (impaired airway homeostasis): Determine if smaller airway tree caliber is associated with attenuated
basal progenitor cell expression signature among never smokers (n=40) and an ‘exhausted’ basal cell gene expression
response to smoking with higher expression of airway inflammation (n=207).
Aim 3 Identify the threshold of airway tree caliber that defines resilient versus susceptible airway tree caliber using existing
cardiac and full-lung CT measures and clinical outcomes with up to 21 years of follow-up (n=9,664).
3a: Test whether airway tree caliber modifies the risk of death associated with tobacco smoking.
The proposed R01 renewal builds upon high-impact prior work and seeks to understand and ultimately target resilient airway
tree development and maintenance across the lifespan and improve population health in the 21st century.

Public health relevance
PROJECT NARRATIVE Airway tree size varies in the general population and is associated with much higher risk of death from diseases linked to smoking and other noxious pollutants. This research grant renewal builds upon prior work to establish the early life-origins of airway tree size, investigate candidate mechanisms that link airway tree size to tobacco smoking-related susceptibility, and define resilient airway tree size using clinical outcomes. These aims represent key gaps in knowledge toward understanding and ultimately targeting mechanisms of resilient lung development and maintenance across the lifespan to prevent disease and improve health in the 21st century.